Genes that Regulate Ethanol Responses in Drosophila

DESCRIPTION (provided by applicant): Alcohol use disorders (AUDs) are a major problem in medicine and society, and the few available treatment strategies have so far met with limited success. It is well established that genetic, psychosocial, and environmental factors contribute to an increased risk for AUDs. Our laboratory has pioneered the development of Drosophila as a model system for the identification of genes and molecular pathways that regulate simple ethanol-induced behaviors, such as intoxication and the development of tolerance, and many of the underlying molecular mechanisms have been found to be conserved between flies and mammals. Here, we propose to investigate the mechanisms underlying more complex behaviors - ethanol consumption, preference, relapse, and reward - in Drosophila. The Specific aims of this proposal are: 1) to characterize in detail, using newly developed software, the behavior of flies during ethanol self-administration and relapse, and study the influences of experience as well as social and environmental context; 2) to define the neuromodulators and neural circuits engaged during these behaviors; 3) to establish whether genes that regulate acute ethanol intoxication also mediate ethanol consumption, relapse and reward, and identify novel genes that regulate these behaviors; and 4) to identify potential pharmacotherapies for AUDs by screening a large collection of FDA-approved drugs for their efficacy in curbing ethanol consumption and relapse. The ease, potential for high throughput, and relatively low expense of Drosophila studies make the fly a powerful system to investigate the molecular and neural mechanisms underlying ethanol preference, relapse and reward. These mechanisms will provide novel insights into these complex behaviors, which can be translated to rodent models, provide candidate genes for the genetics of AUDs in humans, and ultimately, suggest potential targets for pharmacotherapy.

Public health relevance
PUBLIC HEALTH RELEVANCE: We will identify novel mechanisms underlying ethanol self-administration, relapse, and reward in flies, mechanisms which can be then be translated rapidly to preclinical rodent models, provide candidate genes for the human genetics of alcohol use disorders, and suggest new pharmacotherapies for this immense medical and social problem. Project Narrative We will identify novel mechanisms underlying ethanol self-administration, relapse, and reward in flies, mechanisms which can be then be translated rapidly to preclinical rodent models, provide candidate genes for the human genetics of alcohol use disorders, and suggest new pharmacotherapies for this immense medical and social problem. __SpecificAimsTextDelimiter__ a. SPECIFIC AIMS: The original goal of this project was to develop and use Drosophila as a model organism to study the mechanisms by which ethanol acts on the nervous system to alter behavior, and the mechanisms by which the nervous system changes upon repeated or chronic drug exposure. For this purpose, we developed several behavioral assays to measure the acute effects of ethanol on postural control, locomotion and sedation [1-5], assays that also allow the quantification of tolerance [6, 7]. Using these assays, we have carried out genetic screens for mutants with altered behaviors and have characterized several of the disrupted genes [1, 4-6, 20- 24], many of which have since been validated in mammalian systems. Here, we propose to take the Drosophila model to a higher level of sophistication. Specifically, we have developed new behavioral paradigms that allow us to study the mechanisms underlying ethanol consumption, preference, and reward. The Specific Aims of this proposal are: I. To characterize in detail the behaviors of ethanol consumption, preference, and relapse in Drosophila. Our preliminary data demonstrate that flies exhibit a robust preference for consuming ethanol- containing liquid food. The goal of this specific aim is to analyze this preferential consumption and relapse following ethanol deprivation at higher resolution using newly available software. We will investigate the patterns of ethanol drinking and how these patterns change over time and during relapse, potential roles for social interactions and environmental cues, and the effects of prior ethanol experience. II. To define the neurochemical bases and neural circuitry mediating ethanol consumption, preference, and relapse. Our preliminary data indicate that ethanol preference is a complex behavior influenced by sensory inputs, prior experience, and the pharmacological effects of ethanol. Using available and newly developed genetic tools, we will identify the neuromodulators, neuropeptides, brain regions, and neural circuits that mediate these complex ethanol-related behaviors. III. To identify genes and molecular mechanisms regulating ethanol consumption and preference. Unbiased genetic screens in flies have identified several novel molecular pathways mediating alcohol sensitivity and tolerance. In this aim, we will use genetic approaches to identify novel molecular mechanisms that regulate ethanol consumption and preference in flies. We will begin with a candidate gene approach focused on pathways known to affect simpler ethanol responses and then conduct an unbiased forward genetic screen for novel genes. IV. To identify existing drugs that modulate ethanol consumption and preference. To accelerate the translation of Drosophila findings to preclinical rodent models, we will conduct an unbiased screen for compounds that, when fed to flies, affect ethanol consumption and preference. We will use an available library of compounds, "US-drug", that contains 1040 drugs that are either FDA-approved or in Phase 3 clinical trials. Any compound that affects ethanol consumption and/or preference in flies can then be rapidly tested in preclinical rodent models of alcohol use disorders.